EFFECTS OF ANESTHETICS IN INTRAOPERATIVE CHANGES IN SERUM ACTH, CORTISOL

The effects of anesthetics on serum ACTH, cortisol, and prolactin concentrations are poorly understood. In looking at the effects of three commonly employed anesthetic agents (propofol, sevoflurane and isoflurane) in a closely controlled patient population, we will obtain a better understanding of their effects on these neuroendocrine hormones. New protocol